New insights into the role of the Fbw7 tumor suppressor in senescence and aging

Abstract: The goal of this proposal is to uncover the molecular mechanisms by which the Fbw7 tumor suppressor is implicated in cellular senescence. The long-term goals of my career are to apply the insight of molecular and cellular biology to understand the physiological significance of protein degradation machinery that is important in the development of human malignancies and aging-associated disorders. Fbw7 is a substrate recognition subunit of the E3 ubiquitin ligase complex SCFFbw7, which is well known to target numerous cell cycle positive regulators for proteasome-dependent degradation. Recent intensive studies elucidated a crucial tumor suppressor function for Fbw7. However, the molecular mechanism by which Fbw7 is implicated in cellular senescence is currently unknown. Our preliminary data showed that Fbw7 negatively regulates the stability of Raptor and Rictor, the essential accessory proteins of the mTOR complexes (mTORC). The mTOR pathway plays a pivotal role in sensing nutrition and energy in cells. Interestingly, recent studies revealed that mTOR signaling also negatively regulates longevity across species (from yeasts to mice). However, the upstream regulatory pathways governing mTOR activity during the aging process remain largely unknown. We hypothesize that Fbw7 is an upstream negative regulator of the mTOR signaling pathway through which Fbw7 plays an important role in regulating cellular senescence. In this proposal, we plan to: 1) Determine the physiological significance of SCFFbw7 during senescence, 2) Determine the role of SCFFbw7 in modulating cellular senescence via regulation of Raptor and Rictor protein stability, 3) Determine whether regulation of Raptor and Rictor by Fbw7 has a physiological role in controlling aging in hematopoietic stem cells (HSCs). This K01 award will provide protected time for me to pursue the hypotheses of this proposal, obtain new skill sets to execute experiments and solve problems. In addition, the award will also allow me to focus my efforts on independently conducting basic and translational research, and training of future young scientists. Should I receive this award, I will pursue this research in Beth Israel Deaconess Medical Center (BIDMC) and Harvard Medical School, where authorities in the fields of PI3 kinase signaling and cellular senescence locate. The outcome of the proposed studies will help elucidate whether Fbw7 can directly regular aging in vivo, and whether loss of Fbw7 function causes cellular senescence of HSCs via up-regulation of the mTOR pathway, which may contribute to the pathogenesis of leukemia in the elderly population. Importantly, this study suggests that loss of Fbw7 could be a conceivable biomarker for age-related hematological disorders and hence sensitivity to the mTOR specific inhibitors. We expect this will provide evidence toward the rationale for using mTOR pharmacological intervention in personalized medicine for age-related diseases.

Public health relevance
Project Narrative: Aging of hematopoietic stem cells is considered a risk factor for leukemia development in elderly people. This proposal focuses on the molecular mechanisms by which the Fbw7 tumor suppressor participates in aging of hematopoietic stem cells by negatively regulating the mTOR pathway. Therefore, this study would impact the field of clinical hematology in aging and provide a new avenue of pharmacological intervention to treat age- related hematopoietic defects. __SpecificAimsTextDelimiter__ Specific Aims: New insights into the role of the Fbw7 tumor suppressor in senescence and aging Fbw7 is a substrate recognition subunit of the E3 ubiquitin ligase complex SCFFbw7, which is well known to target many cell cycle positive regulators for proteasome-dependent degradation. Recent intensive studies elucidated a crucial tumor suppressor function for Fbw7; however, the molecular mechanism by which Fbw7 is implicated in cellular senescence is uncharacterized to date, and hence is the major focus of this proposal. Our preliminary data showed that Fbw7 negatively regulates the stability of Raptor and Rictor, the essential accessory proteins of the mTOR complex (mTORC) (Fig. 1). The mTOR pathway plays a central role in sensing nutrition and energy in cells. Interestingly, recent studies revealed that mTOR signaling negatively regulates longevity across species. In addition, it was observed that the activity of mTORC1 was significantly elevated in senescent cells, indicating the critical role of mTORC in promoting the aging process. However, the molecular mechanisms and upstream modulators that regulate mTOR activity during the aging process remain largely unknown. In this proposal, we hypothesize that Fbw7 is an upstream negative regulator of the mTOR signaling and thus Fbw7 plays an important role in regulating cellular senescence. To test our hypothesis, we propose the following three specific aims: Fig. 1: Schematic overview of specific aims of this proposal Specific Aim 1: To determine the physiological significance of SCFFbw7 during senescence. Resent studies revealed an intensive crosstalk between senescence and cancer, and senescence has been considered as a natural barrier to suppress tumorigenesis. Interestingly, Fbw7 is reported to be a p53-inducible gene. In this specific aim, we will analyze if expression and activity of tumor suppressor Fbw7 are tightly regulated in replicative and premature senescence in human fibroblasts. Furthermore, we will investigate if depletion of Fbw7 accelerates premature senescence in human cells. Specific Aim 2: To determine the role of SCFFbw7 in modulating cellular senescence via regulation of Raptor and Rictor protein stability. In this Specific Aim, we propose to examine the role of Fbw7 in controlling cellular senescence through regulation of the mTORC1 and mTORC2 activities. Our preliminary data indicates that Fbw7 down-regulates protein levels of Raptor and Rictor. These two molecules confer discrete physiological functions to mTORC1 and mTORC2, respectively. We predict that Raptor and Rictor are direct ubiquitin substrates of SCFFbw7. To test this hypothesis, we will examine if SCFFbw7 complex can transfer ubiquitin onto Raptor and Rictor in vivo and in vitro. Furthermore, we will identify the Fbw7 recognition sequence (degron) within Raptor and Rictor protein sequence, and examine whether Casein Kinsase I (CKI) is the upstream modifying enzyme responsible for phosphorylating the degron to trigger Raptor and Rictor degradation. Moreover, we will further investigate whether mutating the degron sequence abolishes the binding of Fbw7 and ubiquitin transfer to Raptor/Rictor, and subsequent degradation of those proteins. Specific Aim 3: To determine if Fbw7's regulation of Raptor and Rictor has a physiological role in controlling senescence of hematopoietic stem cells (HSCs) in mice. Recently, genetic mice models revealed that bone marrow specific TSC1 (Tuberous Sclerosis 1) knockouts exhibit premature senescence in hematopoietic stem cells (HSCs). TSC1 is known to form a heterodimer with TSC2, and negatively regulate mTORC1 activity. Interestingly, it was reported that Fbw7 knockout mice show a similar phenotype, which displayed hyperproliferation and subsequent depletion of HSCs. Therefore, we hypothesize that loss of Fbw7 might cause cellular senescence of HSCs via up-regulation of the mTOR pathway. To directly examine this hypothesis, we will investigate if the depletion of HSCs caused by Fbw7 abrogation results from augmentation of mTORC activities and subsequent HSC aging. In addition, we will test if the diminished HSC function will be partially restored by treatment with the mTOR inhibitor, rapamycin.